Mechanistic Studies of Replication Initiation in Prokaryotes

PROJECT SUMMARY
A long-term goal of our research is to define the molecular mechanisms underpinning the initiation of cellular
DNA replication. Initiation represents a central commitment to cell proliferation; inappropriate onset of
replication can lead to genetic instabilities, DNA damage, and changes in gene copy number. From a
biomedical perspective, initiation is a keystone pathway that should be susceptible to therapeutic intervention
for controlling bacterial infections and cancers; however, a molecular-level understanding of initiation factors
and their activities is insufficiently complete to advance such efforts.
The present renewal application focuses on the initiation of DNA replication in bacteria. Although a basic
biochemical framework for this process is in place, the mechanistic and regulatory principles by which
replication complexes are assembled remain highly enigmatic. In the past project period, we answered long-
standing questions about how the bacterial replicative helicase is physically loaded onto DNA and how ATP
turnover allosterically controls this process. We uncovered a new conformational switching mechanism in the
replicative helicase that controls the binding of primase, which synthesizes short RNAs to jump-start DNA
synthesis. We developed new insights into how hexameric helicases use ATP to drive nucleic acid
translocation and how small molecules and partner proteins can control these enzymes.
Our past progress paves the way for us to tackle exciting new problems involving initiation. Using structural,
biochemical, and single-molecule approaches, we will address fundamental questions regarding the structural
organization of early-stage replisome formation, the molecular means by which initiation factors exchange
partner proteins in an appropriate temporal order, and the ability of replicative helicases to navigate duplex
nucleic-acid roadblocks. The outcome of the proposed studies will be a mechanistic picture of the major steps
involved in converting a duplex chromosomal region into an elongating replication fork. These findings will
define new principles for the field of DNA replication and the broader action of ATP-dependent machines and
switches; it will also establish new insights and approaches for advancing drug-discovery efforts that target
bacterial initiation systems.

Public health relevance
PROJECT NARRATIVE The initiation of DNA replication is central to cell proliferation and survival. Initiation pathways should be susceptible to therapeutic intervention against bacterial infections and cancers; however, limitations in our understanding of basic initiation mechanisms impede this goal. The proposed work will provide key molecular models for understanding initiation proteins and activities and will establish new assays and approaches for accelerating antibacterial discovery through efforts that target these factors.